MODELING IN ANTI CANCER DRUG DVMT PRECLINICAL STUDIES THOUGH CLINICAL TRIALS

We extended the work described in last year's progress report by attempting to find improved predictors of arousal from an array of variables derived from non-EEG-related measurements. We examined various other respiratory-based measures for correlation to arousal. The following were calculated on an epoch-to-epoch basis and compared to the visually-scored arousal index: (1) the average value of the fuzzy-based severity index, SI; (2) the standard deviation of SI; (3) average inspired tidal volume; (4) standard deviation of tidal volume; (5) the maximum breath-to-breath change in inspiratory peak flow; and (6) the ratio of the maximum tidal volume over the minimum tidal volume. These variables were computed from our database of 13 patients with sleep-disordered breathing. The respiratory-based variable with the highest sensitivity of predicting arousal (75%) was the standard deviation of SI. The respiratory-based variable with the highest specificity in predicting arousal was the standard deviation of tidal volume (81%). However, the sensitivity associated with this variable was only 68%. Thus, the respiratory-related measure with best overall scores in both sensitivity and specificity was the standard deviation of SI.